Prefrontal circuits underlying the maturation of learned avoidance

PROJECT SUMMARY The medial prefrontal cortex (mPFC) makes essential contributions to learning, mood,
and decision making, including evaluating and responding to threats. Compared to other circuits, mPFC circuits
undergo prolonged maturation that is likely necessary in order to support complex behaviors. Yet how the
development of prefrontal circuits enables the maturation of adaptive behaviors is poorly understood. Moreover,
its extended development renders mPFC circuits highly vulnerable to disruption by environmental insults such
as early life adversity (ELA). Even after adverse environmental conditions improve, ELA can produce lasting
alterations in cognitive and emotional processing that put individuals at risk for many psychiatric disorders
including anxiety disorders and depression. Although mPFC circuits are clear therapeutic targets for
psychiatric disorders, substantial gaps in our understanding of typical mPFC circuit development and how this
maturation enables emergence of complex cognitive and emotional behaviors prevent us from designing
effective interventions. Our research will fill this knowledge gap by combining threat avoidance behavioral assays
with projection-specific optogenetic manipulations, activity monitoring, and a model of ELA to test the hypothesis
that precisely timed maturation of PL-BLA and PL-NAc circuits determines age-specific avoidance behaviors,
and by altering the trajectory of circuit development, ELA leads to age-specific alterations in learned avoidance.
In Aim 1, we will use optogenetics to test the hypothesis that the behavioral contribtions of specific mPFC circuits
change over development. In Aim 2, we will use fiber photometry to expose circuit and region-specific activity
patterns during learned avoidance across development. Finally, in Aim 3, we will apply the aforementioned
approaches to a model of early life adversity to understand how chronic early stress impacts the trajectory of
threat avoidance circuit development. This proposal directly addresses a pressing need to understand the
complex relationships between early adversity, mPFC circuit development, and adaptive threat resposnes. Our
research can inform individualized mental health treatments that exploit a variety of developmental opportunities,
depending on the stage at which symptoms emerge.

Public health relevance
NARRATIVE The medial prefrontal cortex (mPFC) makes essential contributions to learning, mood, and decision making, including evaluating and responding to threats. Compared to other circuits, mPFC circuits undergo prolonged maturation that is likely necessary in order to support complex behaviors but also extends the developmental window during which insults, such as early life adversity, can perturb healthy circuit assembly. The broad goal of this proposal is to establish causal links between mPFC circuit development and the maturation of learned threat avoidance, and to determine how ELA impacts this developmental trajectory.